Primary Ovarian Insufficiency: Etiology and Comorbid Disease

Primary ovarian insufficiency (POI) is part of the continuum of ovarian dysfunction ranging from infertility with a
high FSH level to early menopause before age 45 years, and affects 5-10% of women. While it has been
suggested in epidemiology studies that women with POI suffer from cardiovascular disease, osteoporosis and
increased mortality, the breadth of comorbid disease and the relationship between POI and mortality is not
clear. Further, the genetic underpinnings of POI may predispose women to diseases that have not been
defined and may overlap with genes affecting male fertility. We will examine the familial segregation of POI,
male infertility, comorbid disease and mortality to uncover these relationships. We will then apply unique DNA
sequence analysis software developed at the University of Utah to discover novel gene mutations in familial
POI cases and determine whether they also segregate with comorbid disease. Specific Aim 1 identifies
familial cases of POI in the Utah Population Database, the most extensive genealogical database in the U.S.
The inheritance pattern, family size and intersection with male infertility will be examined. Specific Aim 2
examines associated phenotypes, comorbid diseases and mortality in familial POI to determine its effect on
overall health and to determine families at risk for POI. Specific Aim 3 will identify genetic mutations in women
with familial POI through whole exome or whole genome sequencing and determine whether these mutations
also segregate with comorbid disease. We will use novel software (pVAAST and Phevor) developed at the
University of Utah and controls recruited for health in old age to prioritize variants in familial POI. The software
identifies rare, damaging variants in genes that have a strong relationship to the POI phenotype. Variants will
be replicated using three cohorts of women with sporadic POI (n=269). The work addresses fertility as a
marker of overall health by identifying diseases associated with decreased ovarian reserve and POI. It also
illuminates our understanding of the genetics of the reproductive aging transition. Using results from this
proposal, we will be able to determine disease risk in women with POI. Conversely, we will use family history
and associated disorders to identify women at risk for POI. New gene mutations and pathways will inform
software algorithms such as Phevor, which will use the new information to prioritize variants discovered in next
generation sequencing. The algorithms may eventually be used to predict fertility after whole genome
sequencing or determine the genetic cause of POI in additional women. Early identification will bring the
potential to preserve fertility and create targeted treatment options for these women. Conversely, assessing
comorbid disease risk in women with POI will target patients for disease prevention after infertility treatment.

Public health relevance
Narrative The proposal will determine the diseases that are inherited along with primary ovarian insufficiency (POI) in families and the gene mutations underlying POI and associated inherited disease. These studies will help identify causes of morbidity and early mortality in women who present with infertility in the form of POI.